K+ channel complexes: assembly, trafficking and function

The long-term goal of this research is to elucidate the molecular and cellular mechanisms that
ensure potassium (K+) channels assemble with the appropriate membrane-embedded regulatory
subunits for proper physiological function in the heart, muscle, and nerve. In the previous
funding period, we developed an innovative approach to label the t-tubules and sarcolemma of
cardiomyocytes with either small molecule or protein-based K+-sensitive fluorophores. For this
proposal, we will use our fluorescent bioconjugates to test the long standing hypothesis that K+
accumulates faster in the t-tubules to protect the heart during physical activity (Aim 1); to
fluorescently visualize specific ion channel activity in order to identify the K+ channel/KCNE
complexes responsible for maintaining cardiac rhythmicity (Aim 2). The completion of these
aims will yield a transformative set of methodologies to directly investigate extracellular K+
accumulation from heart, muscle, and nerve cells isolated from healthy and disease animal
models.

Public health relevance
The transverse (t)-tubules are a labyrinth of various-sized (nanometers in diameter) invaginations in heart muscle cells that create an intricate network of extracellular ion reservoirs to maintain human heart contractility and rhythmicity. Ventricular heart muscle cells from patients and animal models with cardiomyopathies and ischemic heart failure all have severely disrupted t-tubule networks. Although a healthy human heart requires ventricular t-tubule networks, it has been impossible to experimentally measure potassium concentrations in these nanometer-sized extracellular domains. This proposal overcomes this barrier by developing an approach that enables the fluorescent visualization of potassium in the t-tubules and at the sarcolemma (the non-invaginated cell surface). A greater understanding of the t-tubule’s role in extracellular ion accumulation in healthy and diseased hearts will suggest more effective treatments for hypertrophic cardiomyopathy, dilated cardiomyopathy, ischemic heart failure, and cardiac arrhythmias.